Novel roles for mtGRK2 in heart failure pathogenesis

PROJECT SUMMARY
Heart failure (HF) is a cardiovascular disease (CVD) of major significance, as half of HF patients die within
five years of diagnosis. HF often develops following cardiac injury, when the heart is unable to pump effectively
and compensates by enlarging (hypertrophy) and changing its structure (remodeling). Initially these alterations
maintain normal cardiac output, but the heart cannot sustain the increased energetic demand and eventually
its function decompensates. Therefore, identifying novel therapeutic targets for HF is of utmost importance.
Our lab has studied G protein-coupled receptors (GPCRs) for over two decades, with a focus on G protein-
coupled receptor kinases (GRKs), which phosphorylate and desensitize GPCRs. Two GRKs in particular,
GRK2 and GRK5, are known to be highly upregulated during HF, and this proposal focuses on novel, non-
GPCR roles for GRK2 in HF. Recently,
(mtGRK2)
output,
to
mitochondrial
metabolism.
it has been shown that cytosolic GRK2 accumulates in mitochondria
following cardiac injury or stress, and this event is associated with negative effects on energy
substrate utilization, and ell death. However, the molecular mechanisms by which mtGRK2 contributes
HF are unknown. Preliminary data presented in this proposal confirm that GRK2 interacts with important
proteins, particularly components
Our Central Hypothesis is
c
of the electron transport chain (ETC) and fatty acid
that mtGRK2 plays a critical role in regulating cellular bioenergetics
following cardiac stress. As such, the Specific Aims proposed are to (Aim 1) identify the nature of mtGRK2's
interactions with components of the ETC, and the mechanism of its negative regulation of cellular
bioenergetics; and (Aim 2) determine the mtGRK2-driven metabolic changes seen in chronic HF which
develops following ischemic injury in an animal model of HF, and whether inhibition of mtGRK2 can improve
outcomes by rescuing its negative effects on mitochondrial metabolism. The detailed research strategy
combined with the projected training plan is meant to develop the student into a successful, independent
scientist. All required Ph.D. coursework and requirements for candidacy have been completed by the trainee,
who will continue to receive training in scientific rigor, biomedical ethics, and laboratory safety. Additionally, the
training plan includes an emphasis on career development activities such as publications, talks and seminars,
and attendance at scientific meetings. This proposal further develops the trainee's skills in molecular biology,
biology, pharmacology and cardiovascular physiology; therefore, it is well-suited to strengthening areas which
will be required for a future Principal Investigator in the field of cardiovascular pharmacology.

Public health relevance
PROJECT NARRATIVE G-protein coupled receptor kinase 2 (GRK2) is upregulated during heart failure (HF) and has been shown by our lab to contribute to cardiac dysfunction and worsened outcomes. Our project seeks to determine the role of a recently identified mitochondrial pool of GRK2 (mtGRK2) in the progression of heart failure. This research will contribute to the advancement of HF therapy by identifying novel, pharmacologically targetable mechanisms which are regulated by GRK2 activity.